Top-down regulation of compulsive reward-seeking behavior by medial prefrontal cortex

? DESCRIPTION (provided by applicant): While the drive to seek reward is a fundamental trait shared across many species, when left unchecked it can lead to addiction and substance abuse. A potential therapeutic approach to treating addiction could be to reset the balance between the neural circuits that drive and suppress reward-seeking. To achieve such an approach, we must characterize the specific neural state changes that occur with compulsive reward-seeking, and identify the neural pathways that can reverse this behavior. This proposal aims to use 2photon imaging to reveal the neural activity patterns in the nucleus accumbens (NAc) during a type of compulsive reward-seeking behavior, optogenetic self-stimulation of the ventral tegmental area dopamine neurons. This will reveal the changes in neural dynamics that emerge with repeated, compulsive reward-seeking which underlies addiction. In addition, this proposal will test whether medial prefrontal cortex (mPFC) stimulation is able to exert regulatory action to reduce compulsive reward-seeking by altering the neural activity patterns that are observed in NAc. Finally, this proposal aims to identify which specific mPFC projection neurons drive suppression of reward-seeking behaviors using cell type-specific rabies GCaMP6 and fiber photometry imaging. The findings from this proposed project will provide a novel insight into how NAc circuit dynamics become altered during addiction, and how these changes may be counteracted by top-down executive control from the mPFC.

Public health relevance
PUBLIC HEALTH RELEVANCE: Addiction is not only a huge monetary cost to our country, but it can also have a devastating impact on the lives of those afflicted. In order to expand treatment options, it is crucial to understand the different neural circuits that balance the natural drive t seek reward. This project aims to study the opposing brain pathways that either facilitate or suppress reward-seeking behavior, which may guide future insight into potential therapeutic treatments for substance addiction.